Mechanisms of Metabolicand GLP-1 receptor signaling on Islet hormone secretion

Project Summary
Diabetes is a prominent disease that affects people worldwide and is rapidly becoming more prevalent; it is
estimated that 640 million people will be diagnosed with it by 2040. Defects in β-cell metabolism in pancreatic
islets negatively impact insulin secretion and are associated with diabetes. β-cell metabolism is also controlled
by another cell type in islets, the α-cell, which hypersecretes glucagon in diabetics. Current diabetes therapies,
like glucagon-like peptide 1 receptor (Glp1r) agonists, have side effects like nausea, which prevents it from
completely activating β-cells. Therefore, it is necessary to find an adjuvant therapy to fully treat type 2
diabetes. In this proposal, we identify pyruvate kinase (PK), which converts ADP and phosphoenolpyruvate
(PEP) to ATP and pyruvate in the final step of glycolysis, as a potential target for a new diabetes therapeutic.
We have discovered that β-cell PK, by virtue of its ability to bind and inactivate KATP channels, is sufficient to
initiate and amplify insulin secretion. Preliminary studies suggest that PK activators have the potential to
improve the efficacy of Glp1r agonists. Overall, this proposal will reveal the mechanisms by which PK
activation increases insulin secretion on the molecular level. Our hypothesis is that PK controls α- and β-cell
hormone secretion by closing ATP-sensitive K+ channels. To study this hypothesis, we will: 1) Determine the
direct effect of PK activation on α-cell metabolism and hormone secretion and 2) Determine the therapeutic
potential of combining PK activators (PKa) with Glp1r agonists to enhance insulin secretion in obese mice and
human islets. The effects of PK on α- and β-cell metabolism will be studied using fluorescent biosensor
imaging, electrophysiology, and newly developed 3D light-sheet imaging. Achieving these aims will lead the
characterization of PK’s role in α-cell metabolism and, ultimately, improvement in the treatment of type 2
diabetes.

Public health relevance
Project Narrative Diabetes is a prevalent public health problem that is not fully understood and is characterized by a defect in insulin secretion. Some of the current diabetes treatments have undesirable side effects, so finding a new treatment is critical. In this proposal, the goal is to understand the role of pyruvate kinase in insulin secretion in order to target it for a new diabetes therapy and promote the well-being of the millions who are impacted by diabetes.